STATE TANF CASE STUDIES

The primary purpose of this project is to identify and provide case studies of promising and innovative employment and training programs for TANF recipients and other low-income individuals. OPRE's goal is to increase our knowledge about strategies TANF agencies and workforce development agencies are implementing to help TANF recipients and similar low-income individuals become economically self-sufficient.